Pilot Project Program

The Southwest Environmental Health Sciences Center (SWEHSC) Pilot Projects Program (PPP) supports and
promotes innovative ideas in environmental health sciences (EHS), and advances the strategic vision and goals
of the Center and of the National Institute of Environmental Health Sciences (NIEHS). The grants funded by the
PPP seed new research areas and shape the Center’s research focus. Importantly, the PPP fosters the creation
of productive collaborations that enhance the strength of SWEHSC translational studies and that aid in securing
significant extramural research funds. The Specific Aims of the PPP are to 1) provide initial funding to earlycareer
investigators to establish EHS-related research; 2) support projects that address environmental health
issues in the desert Southwest; 3) encourage established investigators from other fields to develop EHS research
themes; and 4) enable the pursuit of innovative new EHS research directions. Funds to the PPP have been used
successfully to recruit new SWEHSC members and dramatically increase funding from NIEHS and other federal
sponsors to Center members. PPP funded Pilot Projects from the last 10 years have resulted in 19 new ESdesignated
grants to date. Due to the remarkable success of the SWEHSC PPP, SWEHSC has also received
generous institutional support from the University of Arizona (UA) and each of the colleges to support the PPP.
The PPP application process is designed to maximize support to early-career investigators and established
investigators who are new to EHS research. The success of the PPP has been invaluable in supporting the
vision and identity of SWEHSC by focusing on understanding the mechanisms underlying environmental health
risks and diseases among people living in arid Southwest environments.